A novel shift-level approach to optimizing ICU interprofessional team composition for mechanically ventilated adults

PROJECT SUMMARY
At the core of critical care delivery is the interprofessional team, comprised of nurses, physicians, and
respiratory therapists, who provide around-the-clock care to the most critically ill patients. The COVID-19
pandemic underscored the need for a robust critical care workforce and exposed existing structural inequities
in the healthcare system. Research has shown disparities in mechanical ventilation (MV) care and outcomes
based on patient characteristics, such as age and ethnicity. One evidence-based practice associated with
improved outcomes for MV patients—spontaneous awakening and spontaneous breathing trials (SATs and
SBTs)—requires effective coordination and collaboration among the entire team. For decades, researchers
have sought to optimize the organization of critical care teams to enhance patient outcomes. While studies
within individual professions, such as nurses or physicians, have examined the impact of clinician
characteristics (e.g., experience) and scheduling characteristics (e.g., overtime) on outcomes, there remains a
dearth of research investigating how variations in clinician and scheduling characteristics across the entire
team influences patient outcomes. To address this knowledge gap, this application aims to determine how
clinician and scheduling characteristics impact patient outcomes, and explore the moderating effect that
clusters of patient characteristics have on the relationship between clinician and scheduling characteristics on
patient outcomes. We propose a novel secondary analysis utilizing a unique dataset that links electronic health
record data from nearly 17,000 critically ill patients to human resource clinician characteristics of 8,000
clinicians across 5 intensive care units from 2018-2021. Our specific aims are: 1) Test the hypothesis that
patients cared for by teams with better clinician characteristics and scheduling characteristics will be more
likely to receive SATs and SBTs each shift (when eligible), more likely to be extubated each shift, and less
likely to die each shift. Among (n=8,952) MV patients, we will use a patient-level design and a longitudinal,
repeat-measures analysis, where patients serve as their own control. 2) Evaluate the moderating effect of
patient characteristics on the relationship between clinician and scheduling characteristics and patient
outcomes. Among all ICU patients (N=16,940), we will use multiple interactions to identify what clusters of
patient characteristics (e.g., age, sex, race, ethnicity) may be most vulnerable, i.e., experience negative
outcomes, to variation in clinician and scheduling characteristics of the assigned team. If supported by our
findings and replicated in a larger national study, then a patient-centered approach to ICU team assignments
could be a cost-effective intervention that does not require additional staffing. This proposal has the potential to
significantly transform the way interprofessional teams are assigned to ICU patients.

Public health relevance
PROJECT NARRATIVE Intensive care unit (ICU) admissions place a substantial cost on the healthcare system, with over 5 million complex cases annually. To optimize survival rates for ICU patients, interprofessional care teams, comprising nurses, physicians, and respiratory therapists, must collaborate effectively in delivering high-quality, evidence- based care; however, existing research has been limited in examining how the collective characteristics of these teams influence patient outcomes. Our innovative, patient-centered approach, which focuses on evaluating the impact of interprofessional ICU team characteristics on patient outcomes, offers a promising avenue for improving care and outcomes for some of the most critically ill and vulnerable patients.